Administrative Core

The Administrative Core (A) proposed will provide administrative support for the four scientific projects and the clinical laboratory core (B) comprising this program entitled

Public health relevance
The administrative core will facilitate the integration of the research projects that comprise the University of Pittburgh STI-CRC.